Prostate Cancer Biomarker and Imaging Validation Alliance: Emory University, University of Alabama Birmingham, and University of Texas Southwestern

We hypothesize that new biomarkers to refine selecting men for prostate biopsy, together with imaging
innovations to refine biopsy targeting, will enhance prostate cancer early detection by reducing unnecessary
biopsy and over-detection of indolent disease. With this goal, we assembled biospecimen and imaging data via
rigorous SOP's in pre-biopsy cohorts designed to avoid bias. We provided specimens and guidance on PRoBE
adherence to EDRN Labs, NIH Consortia (eg SPOREs) and industry and co-led, in prior cycles, EDRN studies
that facilitated FDA approval of the Prostate Health Index (phi) and urinary PCA3. In the current cycle, we
enrolled 3,263 subjects and distributed 27,072 biospecimens to 25 PI's leading to 56 publications. Our multi-
center phase III validation of an algorithm combining urinary PCA3 and TMPRSS2:Erg (T2:Erg) measurement
validated the cost-effectiveness of this biomarker combination. We then showed significant benefit of
sequentially testing blood phi followed by conditional urine PCA3 and T2:Erg testing. Further, we partnered
with a commercial collaborator having expertise in bringing tissue RNA assays to regulatory approval and
clinical use, to complete whole transcriptome urinary RNA expression analysis in a multi-center case-control
cohort of 587 men, resolving a 33-gene predictive model that significantly improved prediction of aggressive
prostate cancer compared to PSA, clinical factors, or urinary PCA3 and T2:Erg. To advance prostate cancer
imaging, we completed a phase II validation study using the radiotracer fluciclovine (FACBC) in PET-CT to
characterize aggressiveness of prostate cancer at initial diagnosis (to our knowledge, this was first completed
American validation study of FACBC PET-CT for primary, untreated, early stage prostate cancer). For this
renewal, we expand our inclusiveness by adding UAB and UTSW (which, with Emory, enrolled the majority of
African-Americans in EDRN's Prostate MRI trial). For this resubmission, two biomedical engineering
investigators expert in Artificial Intelligence (AI) have joined our CVC, who bring preliminary data supporting a
rigorously developed, retrospectively validated deep-learning MRI AI nomogram to predict PCa on biopsy that
is poised for prospective validation. Based on the combined preliminary data in urinary RNA biomarkers, MRI
AI, and PET imaging from our expanded CVC team, we now propose the following Aims: 1) To validate, by
nested case-control study using PROBE design, the performance of a 33-gene urinary RNA panel in predicting
aggressive prostate cancer on biopsy; 2) To validate a deep learning-based nomogram using MRI AI to predict
aggressive prostate cancer on biopsy 3) To evaluate the performance of PET-MRI in the detection of clinically
significant prostate cancer; 4) To conduct, with CISNET, cost-effectiveness evaluation of the impact of these
new biomarker, imaging and detection techniques. Finally, we commit to continuing to serve as a Collaborative
Resource for the EDRN, through leadership and participation in Set-Aside and Core Collaborative Studies and
provision of biospecimens and blinded clinical data to EDRN BCC's and other collaborating biomarker labs.

Public health relevance
NARRATIVE Our center uniquely combines patient and specimen resources from a breadth of health care settings in/near Atlanta (Grady Memorial Hospital in Atlanta, the Atlanta VAMC in Decatur, St. Joseph's Hospital in Sandy Springs, and Emory University Hospital in Atlanta) together with the University of Alabama in Birmingham and the University of Texas -Southwestern Medical Center in Dallas and partners with laboratories from throughout the U.S. to improve detection of prostate cancer. We also seek to determine which of these cancers should be treated and which ones can be safely managed without treatment.